Targeting EBV's Deubiquitinating Activity for Therapy

Project Summary/Abstract
Epstein-Barr Virus (EBV), a human tumor virus, is the causative agent of mononucleosis and immunoblastic
lymphomas. EBV is strongly associated with Burkitt’s lymphoma, Hodgkin’s lymphoma, and nasopharyngeal
carcinoma (NPC). Additionally, recent studies suggest that EBV has a pathogenic role with the onset of Multiple
Sclerosis (MS). Approximately 90% of the world’s population is infected with EBV, but most do not present
disease. However, for those that do develop EBV-related illness there remains no directed small molecule
therapy. EBV-triggered disease, causing debilitating illness and death, remains a world-wide problem.
Interestingly, EBV expresses a unique protein (BPLF1) that possesses deubiquitinating activity. BPFL1 is known
to regulate both cellular and viral target activities, yet it remains largely unstudied. Our work has implicated
BPLF1 in a wide range of viral and cellular processes including infectivity (90% reduction with knockout of
BPLF1), viral DNA replication, and DNA repair. Also we recently reported surprising new findings that knockout
of BPLF1 delays and reduces human B-cell immortalization and lymphoma formation in humanized mice. The
aim of this proposal is to discover and characterize the first-in-world small molecule inhibitors of BPLF1
deubiquitinating activity. The goals of this proposal are to 1) use high throughput screening to identify novel
chemotypes for a lead optimization effort and 2) produce further validation that small molecule inhibition of BPLF1
deubiquitinating activity is a promising avenue for treating diseases caused by EBV infection. This work will lay
the foundation for a chemical probe and drug discovery effort to combat EBV-associated disease.

Public health relevance
Project Narrative This proposal focuses on the Epstein-Barr Virus deubiquitinating enzyme, BPLF1, that removes the ubiquitin modifier from protein targets and thus affects their function. This proposed research aims to identify an inhibitor of BPLF1 which could serve as therapy for EBV associated diseases.